Arousal and Timekeeping in a Mouse Model of Parkinsonism

PROJECT SUMMARY / ABSTRACT
Movement disorders, such as Parkinson’s Disease (PD) and Huntington’s Disease, are
characterized by drastic impairments in planning and executing movement, as well as cognitive
deficits, some of which stem from deficits in estimating durations. Estimation and reproduction
of durations in the seconds-to-minutes range are critical for fundamental processes such as
associative learning, planned motor responses and decision-making. This project will explore
neurobiological mechanisms involved in the estimation and reproduction of durations to
evaluate timed motor response deficits in mouse models of PD. We will investigate the role of
arousal, and the involvement of a novel neurotransmitter, orexin, in alterations of timed
response selection using a newly developed model of timed response selection deficits in PD.
We will also evaluate pharmacological approaches to rescue motor timing deficits. The project
will enhance our understanding of neuronal processes involved in cognitive and motor control
deficits in movement disorders, and will help develop new treatment strategies in animal
models, with possible subsequent impact on clinical treatments.

Public health relevance
PROJECT NARRATIVE Movement disorders, such as Parkinson’s Disease and Huntington’s Disease, are characterized by drastic impairments in planning and executing movement, as well as cognitive deficits, some of which stem from deficits in estimating durations. By investigating timekeeping in mouse models of Parkinson’s Disease we aim to understand the neural circuits involved in timed response selection. The project will enhance our understanding of the role of these circuits in cognitive and motor control, and will help assessing potential treatment strategies in animal models with subsequent impact on clinical treatments.